Personalizing tDCS Dose in Healthy Adults and Chronic Ischemic Stroke

PROJECT SUMMARY
Stroke is a leading cause of death and disability worldwide. The most common post-stroke disability is weakness
or paralysis in the opposite limbs, which persists chronically (more than 6 months post-stroke) in approximately
60% of patients. There is an ongoing need for more effective post-stroke motor recovery treatments. Transcranial
direct current stimulation (tDCS) is a noninvasive brain stimulation tool that can increase cortical excitability by
applying weak, uniform 1 or 2 milliamp (mA) currents through scalp electrodes. In some existing studies, tDCS
has shown promise for treating post-stroke aphasia and motor impairments by applying stimulation to the
perilesional cortex. However, tDCS outcomes in stroke patients have been inconsistent between individuals and
across studies. This may be due to the lack of personalized dosing. Typically, tDCS studies apply the same mA
dosage to each person. The current one-size fits all approach likely results in underdosing for many individuals.
Early modeling studies on magnetic resonance imaging (MRI) scans, including those in our lab, have shown that
applying a standard 2mA tDCS dose across healthy or stroke participants results in heterogenous cortical electric
fields (E-fields) at the intended target. A solution for personalizing tDCS dose may be reverse-calculation E-field
modeling. This approach accounts for anatomical differences by calculating the individualized mA dosage at the
scalp needed to produce the same E-field in the brain between participants. Thus, using reverse-calculation E-
field modeling could potentially make tDCS more effective for post-stroke motor rehabilitation by personalizing
tDCS dose to ensure that each person gets the E-field they need at the cortical target. While this reverse-
calculation approach is promising, it has only been tested retrospectively. This F31 proposes to prospectively
test the within-subjects effects of personalizing tDCS dose, compared to standard 2mA and sham, on
motor excitability in healthy adults (Aim 1) and chronic ischemic stroke patients (Aim 2). We hypothesize
that personalizing dose with reverse-calculation E-field modeling will produce significantly more consistent tDCS-
induced motor excitability changes (as measured by motor evoked potentials; MEPs) than a standard 2mA dose
or sham stimulation will. An Exploratory Aim will investigate the relationship between baseline functional
MRI (fMRI) measures (resting state functional connectivity strength within the targeted somatomotor
network) and the degree of tDCS-induced motor excitability change. The proposed research will take place
at the Medical University of South Carolina (MUSC) in the Brain Stimulation Lab (BSL), which has a long history
of pioneering brain stimulation treatments for neurological and psychiatric conditions. This F31 proposal
incorporates a wide breadth of training opportunities, including technical skill advancement in neuroimaging and
E-field modeling, advanced statistics, writing and presentation ability, grant writing, and teaching/mentorship.
The training within this F31 application will help the investigator become a leader in personalizing brain
stimulation for post-stroke motor rehabilitation, and launch a career as an independent scientist.

Public health relevance
PROJECT NARRATIVE Stroke is one of the leading causes of disability worldwide, with an ongoing need for effective post-stroke motor rehabilitation. Transcranial direct current stimulation (tDCS) is a promising noninvasive method of stimulating the brain, but the standard approach of applying the same dose for each person may underlie the inconsistent motor rehabilitation outcomes to date. This proposal will investigate a method of personalizing tDCS dose based on individual neuroanatomy (reverse-calculation E-field modeling), which we predict will improve the consistency of tDCS motor excitability effects in healthy adults and chronic ischemic stroke patients.